Engineered tissue arrays to streamline deimmunized DMD gene therapy vectors

A major driver for immunogenicity is the presence of T-cell epitopes within a protein sequence that can activate
helper T cells, resulting in neutralization of the therapeutic effect. For DMD gene therapy, the possibility of T-cell
responses to pre-existing (from revertant fibers) &/or post-treatment dystrophin epitopes has recently emerged
as a serious treatment issue. In the past year 5 DMD patients treated with AAV-microdystrophin (µDys) have
developed T cell mediated immune responses against dystrophin. Based on immunological data, in all cases the
antigenic region was highly suggested to be encoded by exons 8-11.1 Additionally, to being observed in patients
deleted for this region (updates provided at MDA and ASGCT 2022 scientific conferences). A key component of
our approach takes advantage of the fact that a single amino acid can anchor a novel peptide for a preferred
binding state for antigen presenting cells’ via its major histocompatibility complex (MHC) and subsequent T cell
receptor (TCR). It is the TCR recognition which leads to downstream signaling cascades and immune sequelae.
Alternatively, conservatively modified residue(s), can disfavor antigen presentation, preventing dystrophin-
specific immunity. Thus, avoidance of a specific immune response can be achieved if key epitope anchor
residue(s) necessary for antigen presentation are modified to disrupt MHC recognition. Here, our proposal
addresses the fundamental role of immunogenicity against dystrophin that has been found in DMD patients. This
proposal integrates deimmunization protocols and structure-based protein redesign via Rosetta-software, with
streamlined functional testing via our magnetic tissue array (Mantarray) platform-allowing for daily 3D DMD
contractile performance assessment in-a-dish. In turn, dystrophin epitopes can be predicted & ranked according
to their antigenicity by correlating their amino acid sequence content with immunological databases. Known and
predicted epitopes will be targeted for redesign to reduce or eliminate putative MHC-binding peptides and
subsequent T cell activation. Our deimmunization approach will build on previous efforts while focusing on exons
8-11 of dystrophin, & integrating data as it becomes available through any DMD clinical trial alliance that unfolds.
The exon 8-11 region, now part of Pfizers’ updated patient exclusion criteria, encodes a portion of the actin-
binding domain, extending through spectrin-like repeat 1 (note: we have already deimmunized much of exons 6-
8). Importantly, restricting deimmunization efforts to exons 8-11 of dystrophin would be beneficial for all µDys
designs currently in clinical trials. In summary, we propose to deliver deimmunized µDys vectors to human DMD
3D engineered muscle tissues and measure contractile force(s) via our Mantarray system in an effort to screen
for highly functional leading candidates with reduced immunogenicity. To fully validate our 3D muscle system as
a predictive model we will test optimized candidates(s) via rAAV vectors driven by highly muscle specific
regulatory cassettes for their capacity to ameliorate disease progression in the DMDmdx rat model of DMD. These
results will provide necessary preclinical outcome metrics required to advance towards Phase 1 clinical trials.

Public health relevance
Project Narrative We present an innovative strategy for overcoming dystrophin-specific T cell responses by predicting the “strongest” dystrophin epitopes (in register with clinical trial data as it becomes available), then computationally redesigning those epitopes (targeting exons 8-11) to dramatically reduce antigenicity. As a screening platform, novel dystrophin clones will be tested following viral vector transduction of human DMD-iPSC derived engineered muscle tissues and selected based on contractile performance via our high throughput magnetic tissue array platform (Mantarray), followed by in vivo validation within the DMDmdx rat model.